Automated Nucleic Acid Extraction and Purification System to Build Vet-LIRN Testing Capacity

There is a public health need for veterinary laboratories to have significant capacity to test
animal diagnostic specimens and food/feed samples rapidly and accurately for the presence of
important pathogens such as Salmonella, Campylobacter, Listeria and SARS-CoV-2. The FDA
Veterinary Laboratory Investigation and Response Network (Vet-LIRN) is a group of veterinary
laboratories tasked with protecting the health of humans by being able to rapidly and robustly
respond to outbreaks associated with animals and animal products. This equipment-only grant
requests support for the purchase of a KingFisher Duo Prime semi-automated nucleic acid
extraction system. This equipment will expand the capacity of a Vet-LIRN member laboratory
(Ryan Small Animal Hospiital Clinical Microbiology Laboratory at the University of
Pennsylvania’s) to perform additional molecular assays for case investigations and enhance
their capability to handle additional specimens when surge capacity is potentially needed. It will
also the laboratory to more fully engage with proficiency testing and interlaboratory
comparison exercises developed by Vet-LIRN. Assays to be developed or implemented using
thie equipment by the laboratory will include detection of Salmonella, Campylobacter, Listeria
and imipenemase genes from carbapenem-resistant Enterobacterales.

Public health relevance
Molecular detection of pathogens is at the core of modern surveillance and outbreak investigation and response and molecular techniques have been established for use by the FDA’s Veterinary Laboratory Investigation and Response Network (FDA VetLIRN). This equipment-only grant is to support the purchase of the KingFisher Duo Prime automated extraction system for a VetLIRN member laboratory (Ryan Veterinary Hospital Clinical Microbiology Laboratory at the University of Pennsylvania). Purchase of this equipment will expand the capacity of our lab to detect Vet-LIRN targets such as Salmonella, Campylobacter, Listeria, SARS-CoV-2 and antimicrobial resistance genes.